The Goizueta Alzheimer's Disease Research Center

PROJECT SUMMARY/ABSTRACT: ADMINISTRATIVE CORE
The Administrative Core of the Goizueta Alzheimer’s Disease Research Center (GADRC) at Emory University
provides the infrastructure to support and facilitate the growth of clinical and research activities for Alzheimer’s
disease (AD) and related disorders (ADRD), capitalizing on the considerable strengths of the neuroscience
community at Emory. The Administrative Core will provide leadership through the Director, Associate Directors
and Administrator to ensure that GADRC resources are utilized judiciously and effectively to provide the greatest
impact in shepherding the Center’s theme of discovery and translation of new biomarkers and pathogenic
mechanisms that explain pathological and clinical heterogeneity of AD and ADRD to enable greater precision in
early identification, intervention, and ultimately prevention of disease. The Administrative Core will address the
following Aims: 1) Foster active communication, coordination, integration, and planning of all GADRC activities,
including Cores and the Research Education Component (REC), and ensure optimal utilization, leveraging, and
management of resources
; 2) Promote and encourage innovative research to advance our understanding and
treatment of AD/ADRD through the solicitation, review, award, and support of Developmental Projects,
philanthropically supported pilot projects, and junior investigators (REC)
; 3) Enhance AD/ADRD research, clinical
care, and education by maximizing opportunities for interaction with other ADRCs and AD/ADRD investigators,
and with local, regional, national, and international institutions and agencies
; and 4) Cultivate an environment
that promotes the highest standards of ethics in clinical care and research, including compliance with human
subjects, animal welfare, fiscal policies, data accessibility, and scientific integrity and supports diversity, career
advancement and high impact innovative science. The Administrative Core will achieve these Aims by bringing
together talented multidisciplinary researchers from the many departments and centers at Emory and other local
institutions, fostering ongoing and new collaborations with the broader AD research community, engaging the
communities we serve to share the importance of research and research participation and support the training
of a diverse group of future ADRC investigators and leaders.